Diversity Supplements for Imaging Research in Prostate Cancer Health Disparities

PROJECT SUMMARY
African American (AA) men face the highest incidence and mortality rates from prostate cancer (PCa) in the
United States. Prostate multi-parametric MRI (mpMRI) is a non-invasive imaging technique capable of sensitively
detecting prostate tumors by integrating anatomical and functional information. The Prostate Imaging Reporting
and Data System (PI-RADS) currently serves as the standardized scheme for interpreting mpMRI. However, the
existing method for detecting cancerous lesions does not consider racially associated MRI characteristics, and
there is a lack of studies exploring the impact of patients' race/ethnicity on PI-RADS-based interpretation.
Our hypothesis is that racial disparities in PCa diagnosis can be reduced by incorporating racially-associated
MRI measurements with appropriate error correction. We aim to test this hypothesis in a multi-institutional setting
at the University of California, Los Angeles (UCLA) and the University of Alabama at Birmingham (UAB). Our
interdisciplinary team plans to collect and link clinical, radiologic, and histopathologic information using patient-
specific 3D-printed prostate molds, software registration, and expert annotation before and after radical
prostatectomy. The resulting highly curated radiology-pathology dataset will be utilized to (1) characterize the
mpMRI measurement associated with the tumor microenvironment in AA and CA groups, employing co-localized
quantitative radiology-pathology analyses after error correction, (2) investigate whether racially-associated MRI-
based tissue characterization enhances the detection of aggressive PCa, and (3) develop a race/ethnicity-
specific deep learning model for improved detection of aggressive PCa.
This supplementary funding will support a dedicated graduate student, enabling her to receive additional training
in mpMRI and artificial intelligence for non-invasive imaging techniques that enhance the accuracy of risk
stratification in PCa for distinct racial/ethnic populations. Her dissertation goal is to explore the underlying
race/ethnicity-specific biological mechanisms of PCa and reduce prostate cancer health disparities between AA
and CA men through artificial intelligence. To commence her research, she will actively participate in the
acquisition and analysis of co-localized radiologic and histopathologic data with both retrospective and
prospective cohorts (Aim 1). This involvement will equip her to become proficient in the latest imaging techniques
and further investigate racially associated MRI-based tissue characterization (Aim 2). Her training will be
augmented by attending national and international annual meetings and completing courses on Medical Imaging,
MRI physics, and Artificial Intelligence, provided at UCLA. Collectively, these activities will broaden her training
and position her to make fundamental discoveries about improved PCa detection in both AA and CA men,
compared to conventional strategies, thereby reducing racial disparities in detecting aggressive forms of PCa.

Public health relevance
PROJECT NARRATIVE Prostate cancer in African Americans exhibits distinctive features, including heightened aggressiveness, more widespread metastases, earlier onset, and elevated mortality rates compared to those in Caucasian Americans. This diversity supplement aims to provide support for a graduate student candidate, facilitating the exploration of an overlooked yet significant aspect: the development and enhancement of computerized decision support tools to elevate the performance of prostate cancer diagnosis specifically for the African-American population.